P-KIDs CARE: An Intervention to Address Health Systems Delays to Care for Injured Children in Tanzania

PROJECT SUMMARY/ABSTRACT
Every day, 1900 children die from an injury. More than 95% of these pediatric injury deaths occur in low- and
middle-income countries (LMICs), with children in sub-Saharan Africa disproportionately affected. In sub-
Saharan Africa, pediatric morbidity and mortality could be minimized if children with serious injuries received
timely quality care. The objective of the proposed research is to develop and pilot a locally-relevant,
multicomponent intervention to streamline the triage process (e.g. patient assessment, stabilization, and
disposition) for pediatric injury patients in Tanzania. This health systems intervention will work at the first level
of medical contact (e.g., health center and district hospital), in order to facilitate timely disposition and referrals,
and subsequently decrease time to definitive care. The proposed study has three aims: 1) With a mixed
methods approach, describe the barriers to pediatric injury care at the first medical contact; 2) Iteratively
develop the P-KIDs CARE intervention using a nominal group technique and conduct a pre-implementation
assessment and refinement; 3) Pilot the P-KIDs CARE intervention and perform an implementation-focused
formative evaluation. This career development award is being proposed by Dr. Elizabeth Keating, a Pediatric
Emergency Medicine physician-scientist focused on resource-limited settings like Tanzania. During the award
period, the candidate will gain the training and mentorship to become an independent clinical investigator
focused on developing novel, scalable health systems interventions in resource-limited settings. Along with
developing this innovative intervention, the candidate will gain skills in implementation science, health systems
intervention development, global clinical trial design, and the responsible conduct of research. The candidate’s
career development will be guided by an impressive multi-disciplinary and international team of experienced
mentors with extensive expertise in health systems intervention development, global clinical trials, and trauma
management. This proposal speaks to NIH’s strategic goals by building capacity for systems-level trauma
research in LMICs. By the end of this project, Dr. Keating will have a unique combination of research expertise
and will be prepared to submit an R01 proposal that has the potential to improve outcomes for injured children
in sub-Saharan Africa.

Public health relevance
PROJECT NARRATIVE Pediatric injuries are a leading cause of morbidity and mortality in children worldwide. This K23 Career Development Award will develop and pilot test a health systems intervention to streamline the triage process (e.g. patient assessment, stabilization, and disposition), and improve time to definitive care and outcomes of pediatric injury patients. By completing the proposed research and training plans with the support of her multi- disciplinary mentorship team, Dr. Keating seeks to create a scalable intervention to address a critical public health challenge while launching an independent career as a Pediatric Emergency Medicine physician- scientist.